Sexual reproduction and virulence of zygomycete fungi

DESCRIPTION (provided by applicant): Mucor circinelloides and Rhizopus oryzae are the most prevalent causal agents of the deadly fungal infection, mucormycosis, which is an emerging disease in immunocompromised patients and the second most common fungal infection in both hematopoietic malignancy patients and transplant recipients. However, considerably less is known about the virulence of these species compared to other fungal pathogens. This study focuses on the genetics of sexual development and pathogenicity of two zygomycete species complexes. In the studies proposed for M. circinelloides, we will investigate the roles of three genes that encode a triose phosphate transporter homolog, HMG domain protein, and RNA helicase in the syntenic sex locus of three related Mucor sub-species. The expression patterns of these genes during sexual development will be investigated. Disruption mutants of each gene and isogenic strains will be generated to test their roles in sexual development. Our recent studies found evidence that the sex locus may be involved in spore size and virulence of M. circinelloides, in which (-) isolates produce more virulent larger spores when compared to (+) isolates. We will investigate how genes in the syntenic sex locus are involved in spore size determination and virulence in three host models: cultured macrophages, the wax moth Galleria mellonella, and the mouse. In parallel, in the studies proposed for R. oryzae, we will establish a typing system to classify R. oryzae and R. delemar that are two sub-species in the R. oryzae complex. The two sub-species will be discriminated at high resolution based on MLST and lactate dehydrogenase gene sequences. Our preliminary studies indicate that R. oryzae is sexual and saprobic, whereas R. delemar is infertile under laboratory conditions and may be more virulent. We will also further test sexuality of the two sub-species as well as virulence in the wax moth and the mouse to investigate links between sexuality and virulence. Understanding the life cycles and detailed phylogeny of these pathogens will greatly enhance our knowledge to develop new drug targets and diagnostic typing approaches, and may provide the means to control human pathogenic zygomycetes. PUBLIC HEALTH RELEVANCE: Mucormycosis is an opportunistic fungal infection recently recognized as emerging cause of infectious disease with a high mortality rate. However, little is known about the relationship of sexual reproduction to pathogenesis in the zygomycetes compared to other fungal pathogens. This project will provide insight to develop novel drug targets, typing methodology to assign species causing infection, and information that can be applied to control zygomycete infections.

Public health relevance
Relevance of this project to public health Mucormycosis is an opportunistic fungal infection recently recognized as emerging cause of infectious disease with a high mortality rate. However, little is known about the relationship of sexual reproduction to pathogenesis in the zygomycetes compared to other fungal pathogens. This project will provide insight to develop novel drug targets, typing methodology to assign species causing infection, and information that can be applied to control zygomycete infections.